2020 Integrative Physiology of Exercise Conference

2020 Integrative Physiology of Exercise Conference - Project Summary/Abstract The purpose of this proposal is to seek support for the APS Conference entitled “2020 Integrative Physiology of Exercise Conference” scheduled for November 11-13, 2020 in Austin, Texas. The last meeting was held in 2016. This is a premier exercise physiology meeting that focuses on the underlying mechanisms by which exercise benefits health. The field of exercise physiology has a rich history that has provided a foundational framework for key discoveries over the past century related to exercise and health. The 2020 IPE meeting theme will be “Distinguished Past, Bright Future” to build upon this rich history and forward momentum emerging in exercise physiology. The meeting will have a strong emphasis on trainee involvement with activities at multiple levels (oral presentations, posters, workshops, chaperone program and exercise physiology quiz bowl competition - jeopardy style). Since our last meeting in 2016, there have been numerous new developments that need to be reviewed. Of note was that the NIH sponsored Molecular Transducers of Physical Activity Consortium (MoTrPAC) was recently established to build a molecular map to better understand how exercise enhances health and ameliorates disease. The program includes a MoTrPAC symposium to update the scientific community on the progress to date. Additionally, the program reflects recent developments and combines presentations from leading authorities with presentations from young investigators and trainees in exercise physiology. The meeting will concentrate on the role of exercise in health and disease, with an emphasis on translating basic research into applied outcomes across a spectrum of organs/tissues (skeletal muscle, liver, brain, adipose tissue, hormonal communication) and populations (children, young and old adults, untrained, highly trained, diseased, space travelers). Ample time for poster sessions, workshops and planned activities will allow for in- depth discussions among trainees, young scientists and established investigators.

Public health relevance
2020 Integrative Physiology of Exercise Conference - Project Narrative The purpose of this proposal is to seek support for the APS Conference entitled “2020 Integrative Physiology of Exercise Conference” scheduled for November 11-13, 2020 in Austin, Texas. It is critical that we improve our collective understanding of how exercise contributes to health and ameliorates diseases through a whole organism to molecular approach and the associated underlying mechanisms. The meeting will have a strong focus on how exercise contributes to overall health, with an emphasis on translating basic research into applied outcomes across a wide spectrum of organs/tissues (skeletal muscle, liver, brain, adipose tissue, hormonal communication) and populations (children, young and old adults, untrained, highly trained, diseased, space travelers).